Chronic Ankle Instability and Aging: Combined Effects on Physical Function, Joint Health, and Daily Activity

Project Summary/Abstract
Chronic ankle instability (CAI) is a common disorder that can lead to reduced physical function, joint
health, and physical activity. Similar to healthy aging populations, balance and ankle joint health of individuals
with CAI decline from young adulthood to middle adulthood. Age-related changes in balance, walking ability,
reaction time, and strength can both contribute to and result from reduced physical activity. Impairments in
function and declining physical activity are known to increase the likelihood of developing comorbidities and
elevate risk of all-cause mortality in older adults. Older adults with CAI have reduced balance performance
compared to healthy individuals of the same age, indicating that declines in the CAI population are more
pronounced. With respect to ankle joint health, talar cartilage thickness is reduced in approximately 80% of
individuals who have CAI for at least 10 years. However, whether CAI-related declines from young through
older adulthood are steeper than healthy aging adults is unknown. No studies have examined the effects of
CAI on physical activity or ankle joint health in populations aged beyond early adulthood through middle and
older ages. Also, no CAI research has tracked physical activity, ankle joint health, or physical function
longitudinally to examine declines over time. The purpose of this proposed study is to determine the extent to
which CAI and aging independently and interactively affect joint health, physical activity, balance, gait, reaction
time, muscular strength, and perceived function. To accomplish this objective, we will use a longitudinal study
design in which 180 participants will be equally divided across two independent variables: age (20-39, 40-59,
and 60-79 years) and injury history (CAI & control [CON]). The CON group will be matched to the CAI group
based on sex and age. After enrollment, participants will undergo three separate laboratory testing sessions:
Time Point 1 (baseline) Time Point 2 (4 weeks after Time Point 1), and Time Point 3 (12 months after Time
Point 1). In each laboratory session, participants will undergo tests of ankle joint health, balance, gait, reaction
time, strength, and perceived function. Each laboratory testing session will be followed by 7 days of physical
activity tracking using a wearable monitor. To analyze the effects of CAI and aging cross-sectionally and
longitudinally, we will employ a combination of Generalized Linear Model (GLM) and Analysis of Variance
(ANOVA) models that as our primary statistical analyses. Each model will control for potentially relevant
covariates such as injury and disease comorbidities. When appropriate, Tukey post hoc analyses will be
performed, and effect sizes will be calculated. We expect that CAI and higher age will lead to worse
performance cross-sectionally and greater declines longitudinally on measures of joint health, physical activity,
balance, gait, reaction time, strength, and perceived function versus those without CAI and/or of lower age.

Public health relevance
Project Narrative For many adults, the process of aging is characterized by declines in an individual’s balance and walking abilities, as well as reaction time and strength, consequently reducing physical activity, a major health concern resulting in increased morbidity related issues and mortality rates. The presence of chronic ankle instability (CAI), even early in life, is also associated with long-lasting impairments related to physical function, ankle joint health, and physical activity, but how CAI affects age-related declines remains unclear. This study will investigate the combined impact of increasing age and CAI on ankle joint health, physical activity, and physical function.